CRCNS: Computational Modeling of Microvascular Effects in Cortical Laminar fMRI

Today, the most widespread tool for measuring whole-brain activity noninvasively is functional magnetic
resonance imaging (fMRI). Although fMRI tracks neural activity indirectly through measuring the associated
changes in blood flow, volume and oxygenation, recent evidence has suggested that these active
hemodynamic changes in the brain are far more precisely coordinated than previously believed, perhaps at
the fine spatial scale of the basic modules of functional architecture: cerebral cortical columns and layers. If
true, this could enable new studies of brain computation and circuitry as several cortical layers are the well-
known inputs and outputs along canonical feedforward and feedback pathways of brain communication.
The main challenge faced by this emerging field of “laminar fMRI” is how to interpret the complex
hemodynamic signals to infer the underlying patterns of neural activity.
Motivated by this, our overall goal is to improve our ability to measure neural activity from distinct cortical
layers with human fMRI through detailed biophysical modeling of the underlying hemodynamic response.
We will develop a new computational framework to simulate the fMRI signals using realistic microvascular
networks and dynamics of associated blood flow, volume, and oxygenation changes that accompany
neural activity. This framework has been validated using optical microscopy measures of the microvascular
anatomy and dynamics from small animal models, and here we extend it for the first time to the human
cortex. We will combine ultra-high-resolution in vivo vascular anatomical imaging data collected at 9.4
Tesla with our validated algorithm for synthesizing realistic microvascular networks to generate human
vascular models specific to individual volunteers, and use these to simulate fMRI responses to motor tasks
designed to activate specific cortical layers. We will then simulate responses of several forms of fMRI
contrast—that are each sensitive to different aspects of the complex hemodynamic response—and
compare our predictions to high-resolution fMRI measurements. Finally, to gain insight into whether fMRI
can be used correctly to infer neural activity within cortical layers, we will quantify the discriminability of
laminar fMRI by simulating various patterns of neural activity across layers and then comparing the
computed fMRI activation profiles. This will tell us which neural activity patterns can be distinguished from
one another, and which cannot, to help quantify the ability of laminar fMRI to decipher human brain
circuitry. We address a fundamental gap in our knowledge regarding the limits of human fMRI: whether
fMRI can accurately report on activation within distinct cortical layers. Our approach will allow us to quantify
how fMRI sees the neural activity through the “filter” of the vascular response, and provide insight into the
origins of newly-available fMRI contrasts. This will aid in the interpretability of fMRI for both neuroscience
research as well as for translational/clinical research by helping to remove unwanted effects of the
vasculature—to translate the observed fMRI patterns into neural activity patterns to better understand brain
function in health and disease.
RELEVANCE (See instructions):
Functional magnetic resonance imaging (fMRI) is the most widespread tool for measuring activity across
the entire brain noninvasively and has produced much of our knowledge of the functional organization in
the human brain, however fMRI does not measure neuron firing—it detects brain activity by measuring
changes in blood flow in the brain that delivers oxygen to the neurons. Here we seek to develop an
analysis framework that will allow us to more accurately infer which groups of neurons are firing based on
human fMRI data by using computational modeling of blood flow and blood oxygenation changes through
networks of the smallest blood vessels in the brain. Today fMRI is indispensable for experimental human
neuroscience; by improving the neural specificity of this technique, fMRI can become a more reliable tool
for measuring brain function in health and disease, expanding its utility in basic neuroscience and
translational/clinical research including investigations into neurological and psychiatric disease, and may
also provide deeper mechanistic understanding into small vessel disease and other vascular contributions
to cognitive impairment and dementia.
PHS 398 (Rev. 03/2020 Approved Through 02/28/2023) OMB No. 0925-0001
Page 2 Form Page 2
Program Director/Principal Investigator (Last, First, Middle): Polimeni, Jonathan Rizzo